Dentin Sialophosphoprotein (DSPP) and Unfolded Protein Response (UPR) in Dentinogenesis Imperfecta (DGI) and Odontoblast Function

The Unfolded Protein Response, (UPR) is defined as the natural reaction of cells to stresses caused by the
accumulation of misfolded/unfolded proteins within the endoplasmic reticulum (ER). UPR may cause: 1)
degradation of mRNAs encoding secretory proteins, 2) inhibition of global protein synthesis, and 3)
degradation of unfolded proteins that accumulate in the ER. While UPR works to restore ER homeostasis and
promote cell survival, it changes the gene expression of stressed cells and affects their functions, and chronic
(pathologic) UPR may cause various diseases. Non-syndromic dentinogenesis imperfecta (DGI)/dentin
dysplasia (DD), a common inherited dentin disorder, is caused by mutations in one allele of the dentin
sialophosphoprotein (DSPP) gene. Whether DGI/DD is caused by DSPP haploinsufficiency itself or by the
accumulation of mutant DSPP in the ER is not understood. Preliminary in vitro data showed that 1) the
secretion of mouse DSPP-P19L, a homolog of the human DSPP mutant, p. P17L, was impaired in the
transfected cells, and 2) that the chemical chaperone, 4-phenylbutyrate (4-PBA), accelerated the secretion of
mutant DSPP-P19L. Analyses with the recently created DsppP19L/+ knock-in mice showed that odontoblasts in
DsppP19L/+ or DsppP19L/P19L mice failed to efficiently secrete mutant DSPP into the dentin matrix and that the
tooth defects (chamber enlargement) of younger DsppP19L/+ and DsppP19L/P19L mice resembled human DGI Type
III, whereas those at an older age (chamber obliteration) mimicked human DGI Type II. While DsppP19L/+ and
DsppP19L/P19L odontoblasts had a markedly reduced level of DSPP mRNA, they showed an increased level of
the phosphorylated form of inositol-requiring enzyme 1α (IRE1α), indicating the activation of one UPR branch.
These findings lead to the central hypothesis that the mutant DSPP-P19L within the ER causes ER stress
and pathologic UPR, resulting in DGI; alleviation of ER stress by facilitating the secretion of ER-
retained DSPP-P19L may reduce or correct dentin defects. Three Aims are proposed to test this novel
hypothesis: Aim 1 - To determine the pathological effects of intracellularly retained DSPP-P19L on
odontoblasts and dentin formation, by a) examining if DSPP-P19L accumulates in the ER and causes ER
dilation, b) analyzing the dentin defects, c) assessing the activities of all three UPR branches in the molars of
DsppP19L/+ and DsppP19L/P19L mice, and d) determining if UPR associated with DSPP-P19L induces autophagy,
apoptosis and pro-inflammatory responses. Aim 2 - To determine if chemical chaperones will relieve ER stress
and prevent the dental defects of the DsppP19L/+ and DsppP19L/P19L mice, by treating these mice with 4-PBA. Aim
3 - To determine the roles of IRE1α in DSPP mRNA degradation and odontoblast differentiation and function,
by a) assessing the influences of IRE1α activation and inactivation on DSPP mRNA, and b) analyzing the teeth
of mice in which IRE1α is conditionally ablated. Completion of the proposed project will elucidate the molecular
pathogenesis of DGI and help develop effective and non-invasive treatment modalities for DGI.

Public health relevance
PROJECT NARRATIVE Non-syndromic dentinogenesis imperfecta (DGI)/dentin dysplasia (DD) is an inheritable dentin disorder caused by mutations in the dentin sialophosphoprotein (DSPP) gene. Both deciduous and permanent teeth are affected in DGI patients, whereas the permanent teeth are less affected in DD patients. The goals of the proposed research project are to determine the molecular pathogenesis of DGI associated with DSPP mutations and to develop an effective and noninvasive therapy for future clinical management of DGI patients.